Optimizing the Efficacy and Safety of CD33-Targeted Immunotherapy for Acute Myeloid Leukemia and Other CD33+ Disorders

ABSTRACT
Therapies targeting CD33 have long been pursued to improve outcomes in acute myeloid leukemia (AML).
Longer survival with the CD33 monoclonal antibody (mAb)-drug conjugate gemtuzumab ozogamicin (GO)
validates this approach. However, CD33 is a challenging target: several drugs have failed clinically, and benefit
with GO is restricted to AML patient subsets. As one possible shortcoming, almost all CD33-directed drugs,
including GO, recognize the membrane-distal V-set domain of CD33. As a basis for new therapies, the laboratory
of the Unit Director (Roland B. Walter, MD PhD MS) has raised new, fully human mAbs not only against the V-
set domain but also the membrane-proximal C2-set domain of CD33; the latter show enhanced effector cell
functions and target all naturally occurring CD33 variants (i.e., are “CD33PAN” mAbs). With these mAbs now
available, the Walter Lab will conduct well-controlled mechanistic in vitro and in vivo studies to optimize the
efficacy and safety of CD33-targeted therapy, with the explicit goal of patient application. We will primarily focus
our efforts on radioimmunotherapy (RIT) with the alpha particle emitting radioisotope astatine-211 (211At),
leveraging the exquisite radiosensitivity of AML cells, the high potency and target cell selectivity of 211At, and our
institutional infrastructure and expertise in bringing 211At-based RIT from the bench to the clinic. Because CD33
is also displayed on normal blood cells, CD33-targeted drugs cause significant “on-target, off-AML cell” toxicity,
most notably prolonged, profound myelosuppression. Therefore, in parallel to our work on maximizing the
efficacy of CD33-targeted therapy, we are also developing novel gene editing approaches to protect normal
hematopoietic stem and progenitor cells from these drugs to widen their therapeutic window and make their use
safer. The Research Specialist, George S. Laszlo, PhD, has been a member of the Walter Lab since its inception
in 2010. He has been responsible for the training, guidance, and supervision of all technicians as well as the
development and validation of all experimental methodologies, approaches, assays, and generation of all
tools/reagents that, together, built the foundation for the NCI-supported research program on optimizing CD33-
directed therapy as well as several other NIH-supported research projects that the Walter Lab is involved in. A
total of 22 peer-reviewed joint publications between Drs. Laszlo and Walter (9 with Dr. Laszlo as first author)
document their fruitful work relationship. Over the next 5 years, Dr. Laszlo will be essential for the conduct of our
studies described in this application, with key roles in the generation, production, purification, and
characterization of recombinant mAbs and derived therapeutics, the development of genetically engineered cell
line-based tools for drug testing, and the in vivo assessment of drug efficacies against human AML cells. With
his skills and expertise, Dr. Laszlo will be indispensable for our efforts to develop new, efficacious CD33-targeted
drugs in a stream-lined process for the benefit of patients with AML and other CD33+ disorders, for whom current
therapies are often ineffective.

Public health relevance
PROJECT NARRATIVE Widely expressed on acute myeloid leukemia (AML) cells, CD33 is of great interest as a therapeutic target for this highly aggressive blood cancer, but current CD33-directed drugs are often ineffective. Using newly raised CD33-binding antibodies, the Walter Lab plans to optimize the efficacy and safety of CD33-targeted therapy, focusing efforts on the delivery of highly potent radioisotopes, a treatment approach called radioimmunotherapy. Dr. George S. Laszlo, PhD, the Research Specialist in the Walter Lab since 2010, has developed all experimental methodologies, approaches, assays, and tools/reagents that build the foundation for this research and will lead studies over the next 5 years that have the explicit goal of bringing new therapy options to patients with AML.